Defining the molecular mechanisms regulating the hexosamine-N-glycosylation pathway in glioblastoma

ABSTRACT
Glioblastoma (GBM) is the most common primary brain tumor with a median survival of only 12-15 months
despite advanced therapies. These disappointing clinical outcomes indicate that more efforts are required to
better understand GBM pathogenesis in order to provide the foundation for identifying new effective approaches
to target GBM. Research in our laboratories has focused on understanding the underlying mechanisms driving
metabolism alterations in GBM. We demonstrated that SREBP-1, a master transcription factor regulating
lipogenesis, is highly upregulated in GBM by oncogenic EGFR/PI3K/Akt signaling. More recently, we found a
novel molecular connection between the hexosamine biosynthesis pathway (HBP) and SREBPs. We
demonstrated that glucose, through the HBP pathway, increases the N-glycosylation of SCAP, the key
transporter for SREBPs, promoting SREBP activation and lipid synthesis. However, the mechanisms
regulating the HBP-N-glycosylation pathway in GBM and other malignancies are poorly understood.
Moreover, the importance of this pathway in GBM growth is also unknown. HBP is regulated by the GFAT1,
GNPNAT1, PGM3 and UAP1 enzymes that sequentially convert fructose-6-phosphate to UDP-GlcNAc, the key
metabolite for initial synthesis of N-glycan, which is regulated by the DPAGT1 enzyme. To explore how the HBP-
N-glycosylation pathway is regulated in GBM, we performed multiple preliminary experiments showing that: 1)
all the enzymes above are highly expressed in tumor tissues from GBM patients; 2) EGFRvIII, a constitutively
active EGFR mutant, significantly upregulates the expression of these enzymes in GBM cells; 3) pharmacological
inhibition of SREBP-1 markedly reduces the protein levels of all enzymes, while only downregulating the mRNA
levels of GFAT1, PGM3 and UAP1; 4) removing N-glycan binding using PNGase significantly increased the
mobility of GNPNAT1 and DPAGT1 on SDS-PAGE, indicating that both enzymes are modulated by N-
glycosylation. Based on these preliminary data, we hypothesize that SREBP-1, activated by oncogenic EGFR
signaling, transcriptionally upregulates GFAT1, PGM3 and UAP1 expression to enhance hexosamine
synthesis, which in turn promotes the N-glycosylation of GNPNAT1, DPAGT1 and SCAP to increase their
stability and activity, leading to a feedforward loop enhancing HBP-N-glycosylation and lipogenesis to
promote GBM growth. In this study, we will determine the transcriptional regulation of GFAT1, PGM3 and UAP1
by EGFR-SREBP-1 signaling, and delineate the regulation and role of the N-glycosylation on GNPNAT1 and
DPAGT1 proteins in GBM (Aim1). We will further elucidate the importance of HBP-N-glycosylation on GBM
growth by examining the effects of genetic inhibition of GFAT1 or mutation of GNPNAT1 or DPAGT1 N-glycan
binding sites on tumor growth (Aim 2). Completion of this study will significantly improve our understanding of
GBM biology and provide insights for the development of potential new strategy to combat this deadly cancer.

Public health relevance
Relevance to public health Glioblastoma (GBM) is the most common primary brain tumor in adults and one of the most deadly cancers, with a median survival of 12-15 months. This application aims to delineate the novel molecular mechanisms underlying the upregulation of the hexosamine synthesis-N-glycosylation pathway in GBM that is important for tumor growth. Completion of this study will significantly advance our knowledge of GBM pathogenesis and cancer biology, and will also provide insights into potential therapeutic approaches for GBM treatment.